User Training and Research Project for CBMS

Abstract – User Training and Outreach
The main goal of the User Training and Outreach Core within the Center for Biomolecular Structure (CBMS) is
to prepare researchers to make the most efficient use of the Center’s resources; to communicate the diverse
technical capabilities available at the Center, in part to recruit new users; and to provide clear information on
the multidisciplinary aspects covered by the resources in the Center. Training includes one-on-one training
sessions, and technique-focused workshops. In conjunction with online manuals and video clips, CBMS training
provides researchers with a user-friendly platform to access and effectively employ available facilities. Further
outreach activities include participation in conferences and workshops, and the development of a webpage to
inform the larger community.